THE ASSOCIATION OF BIOMARKERS OF ENDOTHELIAL FUNCTION WITH PROSPECTIVE CHANGES IN KIDNEY FUNCTION IN SICKLE CELL ANEMIA

Sickle cell disease (SCD) is a severe monogenic disorder which affects approximately 80,000 patients in the US. It is characterized by a vasculopathy with involvement of multiple organs and resulting in complications such as chronic kidney disease (CKD). Despite the high prevalence of CKD in patients with SCD and its known association with increased mortality, the natural history of CKD in this setting and the factors associated with changes in kidney function remain incompletely defined. Furthermore, the available treatment options for albuminuria, an early manifestation of CKD, in patients with SCD are limited. In fact, no controlled studies have confirmed the long-term efficacy of angiotensin-converting enzyme (ACE) inhibitors, the current “standard of care.” There is increasing evidence for a contribution of endothelial dysfunction to the pathophysiology of albuminuria in SCD. The association of biomarkers of endothelial function with albuminuria provides opportunities, not only to assess the effect of therapies which improve endothelial function, but also to evaluate the predictive value of these biomarkers for a decline in kidney function. Our overall hypothesis is that biomarkers of endothelial function will be predictive of patients with sickle cell anemia at high risk for a decline in kidney function (decrease in estimated glomerular filtration rate and increase in albuminuria). The analyses that we plan to perform would allow us to identify those patients who are most likely to benefit from early treatment and will facilitate the development of targeted therapies. In addition, this study will enable the development of a biorepository of urine and plasma samples for future evaluation of the associations of changes in metabolic profiles and other novel biomarkers with a decline in kidney function. In this application, we will evaluate the rate of change of kidney function (eGFR and albuminuria) over 36 – 48 months; evaluate the cross-sectional association of biomarkers of endothelial function and clinical characteristics with kidney function; and evaluate the cross-sectional association of urine and plasma metabolomics profiles with kidney function. Finally, we will identify biomarkers of endothelial function, metabolomic profiles and clinical characteristics for a worsening in kidney function and for a rapid decline in kidney function, based on a decrease in eGFR of ≥ 2.5 mL/min per 1.73 m2 per year. At the conclusion of our proposed work, we will have an improved understanding of the natural history of CKD in sickle cell anemia. There are limited available therapies for the treatment of early CKD in patients with SCD and there is a paucity of data on the long-term efficacy of available pharmacotherapies. Identification of biomarkers for the progression of CKD will facilitate the development of treatments which may be more effective than the current “standard of care.”

Public health relevance
PROJECT NARRATIVE Despite the high prevalence of chronic kidney disease (CKD) in sickle cell disease (SCD) and its association with increased mortality, the natural history of CKD in this setting and the factors associated with changes in kidney function are not well defined. In this application, we will evaluate the age- and sex-adjusted rate of change, over 36 - 48 months, in kidney function (estimated glomerular filtration rate and albuminuria) in patients with sickle cell anemia; and identify biomarkers of endothelial function, metabolomic profiles and clinical characteristics for a worsening in kidney function and for a rapid decline in kidney function, based on a decrease in eGFR of ≥ 2.5 mL/min per 1.73 m2 per year.